Micrococcal nuclease-triggered antibiotics release: a prophylactic implant coating against S. aureus infections

PROJECT SUMMARY/ABSTRACT
Periprosthetic infections is one of the most serious complications in orthopedic surgeries, occurring in 1-4% of
primary total joint replacement and up to 30% of revisions. Infections caused by Staphylococcus aureus (S.
aureus), the most prevalent microbial culprit in orthopedic infections, are particularly hard to treat due to their
tendency to form biofilms on implant and notorious ability to invade the canalicular network of surrounding
bone. Existing prophylactic antibiotic deliveries involve high drug doses that are unsafe yet ineffective and
could lead to the development of drug resistance. Utilizing an oligonucleotide linker labile to S. aureus
micrococcal nuclease (MN) cleavage, we recently developed a hydrogel capable of on-demand release of
covalently tethered vancomycin. When applied as a hydrogel coating to Ti6Al4V intramedullary (IM) pin and
inserted to mouse femoral canal inoculated with S. aureus, the MN-triggered release of vancomycin timely
killed the bacterial on implant surface and within IM space before they had a chance to colonize or invade
surrounding bone, thereby preventing biofilm formation and osteomyelitis development in the 3 weeks
examined. The covalent tethering dose of vancomycin in this coating was orders of magnitude lower than the
typical prophylactic antibiotic content used clinically. The goal of the proposed study is to further engineer this
exciting on-demand drug release system to enhance its serum stability and rigorously examine its efficacy in
providing sustained protection against periprosthetic infections using two clinically relevant implant infection
models. In Aim 1, the oligonucleotide linker is chemically modified by selective 2'-O-methylation and
phosphorothioate modifications to achieved enhanced mammalian serum nuclease stability while maintaining
necessary sensitivity to MN cleavage. In Aim 2, the in vitro optimized nucleotide linker will be implemented in
MN-sensitive hydrogel coating and applied to Ti6Al4V IM pins for on-demand delivery of vancomycin. The
efficacy and safety of this prophylactic coating in providing timely and sustained protection against S. aureus
periprosthetic infections will be rigorously evaluated over 6 months using a rat femoral canal infection model. In
Aim 3, the efficacy of this on-demand antibiotic release strategy in reducing the high periprosthetic infection
rates following surgical debridement of previously infected rat femoral canal will be examined using a rat IM
implant revision surgery model. The degree of infections as a function of pin coating and bioluminescent S.
aureus inoculation are longitudinally monitored by bioluminescent imaging and µCT quantification of cortical
bone thickening at 2 weeks, 1, 2, 3 and 6 months, and by end-point quantification of bacteria on the retrieved
pin, torsion test of explanted femur and femoral histology at 1, 3 and 6 months. Long-term safety of the coating
is examined by systemic organ pathology at the endpoints. Systemic injections of vancomycin at a dose
several hundred-fold higher than that in the prophylactic coating are carried out in a subset of infected animals
receiving uncoated IM pins to allow direct comparison of the efficacy of this prophylactic coating vs. that of the
standard care. Achieving more sustained protection against periprosthetic infections or recurrent infections
than systemic vancomycin injections will be considered a success while achieving extended protection for 6
months without local and systemic side effects will be considered exceptional. If successfully validated, the
timely and sustained eradication of bacteria enabled by MN-triggered vancomycin release could bring together
safety and efficacy in addressing the daunting challenge of orthopedic implant-associated infections by
bypassing the notoriously hard-to-treat biofilms and osteomyelitis.

Public health relevance
PROJECT NARRATIVE Prosthetic infection of metallic implants is one of the most serious complications in orthopedic surgeries, occurring in 1-4% of primary total joint replacement and up to 30% of revisions. Existing prophylactic antibiotic delivery involves high drug loading doses that are unsafe, ineffective and could lead to the development of drug resistance. The proposed metallic implant surface coating strategy enables on-demand release of covalently tethered antibiotics in a timely and sustained manner, bringing together safety and efficacy in addressing the daunting challenge of periprosthetic infections. Page 5